Algorithm-enabled Patients Activated in Cancer care through Teams (A-PACT) toimprove goals of care communication for people with cancer

Project Summary/Abstract
For patients with cancer, goals of care (GoC) conversations regarding prognosis, values, and advance care
planning are a critical but greatly underutilized component of oncology practice. Early GoC communication
among patients with cancer reduces unwanted care utilization (hospitalization), improves patient mood (anxiety
and depression), and improves communication regarding care preferences. However, reliance on oncology
clinicians to identify appropriate patients who need urgent conversations and to initiate these conversations in
clinic are major barriers to GoC communication. To that end, we developed Patients Activated in Cancer care
through Teams (PACT), a six-month telephonic lay health worker-(LHW)-led intervention to deliver structured
education and engage patients in GoC conversations between oncology clinic visits. In single-institution
efficacy studies, PACT doubled GoC conversations and halved end-of-life hospitalizations. Reliance on
research or clinical staff to manually abstract eligible patients for PACT limits scalability in busy community
oncology settings, where most patients with cancer receive their oncology care. To address this critical gap, we
developed and demonstrated feasibility of Algorithm-Enabled PACT (A-PACT), which uses machine learning
algorithms to automatically identify high-risk patients to expedite referral to PACT. We have demonstrated both
prospective and external validation of this machine learning algorithm in community oncology. Building on our
studies showing efficacy, we propose to test A-PACT’s effectiveness on healthcare utilization and patient-
reported outcomes and explore factors shaping effectiveness and implementation across community oncology
sites, using a hybrid type I effectiveness-implementation study. Our randomized trial is conducted through
NCI’s SWOG Cancer Research Network and implemented in NCI’s National Community Oncology Research
Program, a network of >1000 cancer practices nationwide. We test the effectiveness of A-PACT on reducing
hospitalizations and intensive end-of-life care (aim 1) and on improving patient-reported anxiety, depression,
and metrics of communication and care preferences (aim 2). To guide scale and reach in community oncology,
we will assess how patient, caregiver, clinician, and organizational factors shape A-PACT effectiveness using
mixed-methods guided by implementation science frameworks (aim 3). The A-PACT intervention is innovative
for its multi-level approach and integration of machine learning to scale access to lay health worker GoC
engagement. The proposal is innovative in using principles of implementation science and by producing
dissemination toolkits for algorithm and lay health worker workflows to guide future scale in diverse oncology
settings. Responding to PAR-24-072 (Cancer Prevention and Control Clinical Trials Grant Program) and NCI’s
NOSI on use of telehealth in cancer-related care (NOT-CA-21-043), this proposal, if successful, will provide a
scalable framework to engage patients with cancer in earlier GoC communication in order to reduce unwanted
care utilization and improve patient-reported outcomes, particularly near the end-of-life.

Public health relevance
Project Narrative Our objective is to improve education and engagement in goals of care communication for high-risk patients with cancer, in order to reduce care utilization and improve patient-reported mood and communication regarding care preferences. Through a type 1 hybrid effectiveness-implementation study conducted through NCI's SWOG Cancer Research Network and implemented in NCI's National Community Oncology Research Program, we will evaluate the effectiveness of a scalable approach combining automated machine learning- driven patient identification with lay health worker-led engagement in goals of care communication. We will also identify patient, caregiver, clinician, and organizational characteristics affecting effectiveness and implementation outcomes, in order to facilitate broad adoption.